The Ecology of Barrett's Esophagus

Summary
Barrett’s esophagus (BE) is the only known precursor to esophageal adenocarcinoma (EA), a highly lethal
cancer, the incidence of which has been rapidly increasing in the US. Currently, we over-treat the vast majority
of patients with BE who will never progress to EA, and under-diagnose those that will progress. However, the
ecological constraints and pressures driving phenotypic changes in BE, and the evolution of EA, are currently
poorly understood. Our goals are to interrogate the BE tissue ecosystem to map the cellular,
microenvironmental, and phenotypic diversity, and to compare the ecological microenvironment in BE patients
that progress to EA to those in which BE remains stable over long periods of time. In Aim 1 we will develop a
computational method to test if the spatial structure of different cell types in BE biopsies predicts progression to
cancer. Aim 2 develops computational methods to detect abnormal cell proliferation at the top of Barrett’s
glands which predict progression to EA. Aim 3 develops deep learning methods and tests if they can detect
DNA content abnormalities (increased 4N fractions and aneuploidy) which predict progression to EA. These
aims are biologically interconnected, profiling the BE tissue ecosystem, yet are technologically independent.
We will use state-of-the-art computer vision machine learning tools to automate quantitative analyses of the
spatial distribution of key cell types in the BE ecology. Machine learning, both self-supervised and trained by
expert pathologist annotations in conventional H&E images, will unambiguously identify multiple specific cell
types and quantify spatial patterns of unique cell habitats on biopsy sections. We will test if these BE tissue
ecology measures, in combination and separately from abnormal cell proliferation and genomic abnormalities,
distinguish those who progress to cancer from those who remain cancer free during follow-up, to improve
clinical care of individuals with Barrett’s esophagus. We will leverage our unique cohort of longitudinally
collected BE tissue biopsies, analyzing 5,760 digital tissue section images (split evenly into training and test
sets) from patients in the Seattle Cohort to develop spatio-temporal tissue maps at cellular resolution in BE as
it progresses to EA. We will validate all our results in an independent cohort from UCSF. The Project brings
together expertise in machine learning, computer vision, and digital pathology (Yuan), Barrett’s pathology
(Stachler), statistical landscape ecology (Brown), Barrett’s esophagus (Grady, Paulson), BE clinical care
(Grady), computational biology and the evolution of BE (Maley) to develop computational pathology systems to
quantify the ecology, phenotypic heterogeneity, and genomic abnormality within the BE microenvironment. Our
pipeline for calculating landscape ecology statistics to measure tumor microenvironments can be used on any
tissue for which we have cell locations and classifications. Digital datasets and computational tools will be
made publicly available, providing a rich resource for the early detection of cancer and cancer prevention
communities, as well as clinical tools for BE patient care.

Public health relevance
Narrative Pre-cancer cells live in a cellular ecology composed of a variety of different kinds of immune cells, support cells, and pre-cancer cells. The goal of our project is to characterize that ecology in patients with Barrett’s esophagus (a pre-cancer) that later developed esophageal cancer, and see if it is different from the ecology of Barrett’s esophagus tissue in patients that never developed esophageal cancer over a long period of observation. If we are successful, our measures of the Barrett’s esophagus tissue could be used to identify cases of Barrett’s esophagus where we should intervene, from those patients that we can reassure and send home without worry of developing cancer.